Clinical Scholars Biomedical Research Training Program

ABSTRACT
The Clinical Scholars Biomedical Research Training Program (CSTP) at Memorial Sloan Kettering Cancer
Center (MSK) provides a mentored laboratory training experience in cancer research for outstanding MD and
MD/PhD residents/fellows who are emerging clinician-scientists. The CSTP is unique among training programs
at MSK since it prepares clinically active investigators, from a range of research disciplines, to pursue research
across the translational research spectrum. The goal of the program is to prepare highly qualified physician-
scientists for an independent research career at the interface of cancer biology and clinical research. The
Clinical Scholars in CSTP are trained by principal investigators with an exceptionally broad range of scientific
interests spanning most areas of modern cancer research. Out of 42 preceptors, 27 (67%) are physician-
scientists who excel at laboratory research, clinical research, and academic clinical practice and represent
strong role models for young investigators pursusing careers in oncology research. The CSTP consists of a
structured and cohesive two-year curriculum that combines laboratory research, didactic course work in cancer
biology, bioinformatics and computational training, and career development workshops. Trainees have access
to all resources of MSK, an instituion where basic, translational, and clinical research activites take place in
close proximity in a highly collaborative research environment. The research areas of principal emphasis
include: 1) human cancer biology, mouse models of cancer, genetics, epigenetics and molecular pathology; 2)
drug development and mechanism-based therapeutics; 3) signaling pathways involved in control of cell
proliferation; 4) regulatory pathways involved in developmental biology and cell differentiation; 5) cell-cell
interactions, adhesion and protein targeting; 6) tumor immunology, immunotherapy and transplantation biology.
The CSTP has had a long and successful training history with nearly all of its graduates continuing in highly
productive biomedical research careers. Thus, the CSTP has had signficant impact in meeting the national
need for physician-scientists who can play leading roles in translating basic discoveries in cancer biology into
clinical practice.

Public health relevance
NARRATIVE Physician-scientists functioning at the interface between laboratory research and clinical practice play a critical role in the translation of scientific discoveries into new diagnostics and therapeutics. The Clinical Scholars Biomedical Research Training Program (CSTP) is designed to prepare board eligible/certified physician- scientists to carry out independent laboratory-based research aimed towards clinical translation. These individuals will increase our understanding of the pathogenesis of cancer and lead the development of new cancer treatments.